The brain bases of magnitude processing in children with math disability before and after math intervention.

PROJECT SUMMARY / ABSTRACT
Numerical magnitude processing allows us to comprehend and compare quantities, in both symbolic and
non-symbolic formats. This skill is thought to be critical for successful math learning, as evidenced by
correlations between performance on numerical magnitude processing tasks and both concurrent and future
math achievement. Magnitude processing has been reliably shown to recruit the brain’s frontoparietal network,
including the intraparietal sulcus (IPS) and inferior frontal gyrus (IFG). Developmental dyscalculia, or math
disability (MD), affects 6-14% of the population and is characterized by poor accuracy and fluency with
arithmetic. Children with MD frequently show poor magnitude processing ability, as well as differences in
frontoparietal brain activity when performing magnitude processing or arithmetic tasks. Despite prior research,
the relationships between the brain regions that subserve magnitude processing and performance on specific
math skills in children with MD are poorly understood. Further, to address the causal nature of any such
relationships, it is necessary to characterize whether brain function during numerical magnitude processing
changes following intervention (through tutoring in math), and if this brain function relates to the extent of the
performance gains made in math skills following intervention. If poor magnitude processing is a cause of MD,
then brain networks supporting this skill should be directly related to performance on specific math tasks.
Furthermore, changes in brain function should accompany changes in these math tasks in response to the
intervention. Where and whether these functional changes occur will be indicative of whether there is a role of
the frontoparietal magnitude processing network in successful treatment.
In the proposed study, I will investigate magnitude processing and its neural correlates (using fMRI) in
children with MD, both cross-sectionally (Aim 1) and longitudinally in the context of an intervention (Aim 2). In
Aim 1, I will assess whether activity and functional connectivity (FC) during a magnitude processing task
correlate with performance on specific tests of math achievement. We expect to find correlations with math
skills that rely on procedural computation (rather than verbally-mediated fact retrieval), due to its reliance on
magnitude representations. In Aim 2, using data before and after math intervention, I will first investigate
whether baseline (pre-intervention) activation/FC of frontoparietal regions (including IPS and IFG) predicts
future gains in magnitude-reliant math subskills (2a). I will also assess pre-to-post activation/FC change in
these magnitude processing regions (2b), and whether the degree of functional change correlates with degree
of behavioral performance change (2c). Through these results, we will gain a better understanding of the
relationship between magnitude processing in the brain and behavior, and furthermore whether changes in
brain function in magnitude processing regions are the mechanism of successful math learning in MD. The
results will shed light on the specific role of magnitude processing in math (dis)ability and in treatments of MD.

Public health relevance
PROJECT NARRATIVE Developmental dyscalculia, or math disability (MD), is a common learning disability that severely hinders academic and vocational success. MD is associated with aberrant brain activity in a frontoparietal network, but little is known about how brain function during processing of numerical magnitudes: (i) relates to a range of different math skills; (ii) predicts the amount of gains in these math skills following intervention (tutoring in math); and (iii) changes as a result of the intervention. The answer to these questions will deepen our understanding of the role of magnitude processing in MD and shed light on the mechanisms of successful treatment.